Administrative Core

Project Summary – Administrative Core
The purpose of the Administrative Core will be to provide scientific leadership, administrative support, and fiscal
management for the Michigan Infectious Disease Genomics (MIDGE) Center. Our overall strategy is one that
brings together genomic sequencing and functional genomic assays to identify pathogen determinants of
epidemic success across four major pathogen groups. Leveraging synergies across the Center to successfully
execute these projects will depend on coordination from the Administrative Core. Dr. Adam Lauring will serve as
the Contact PI and the Project Lead of the Administrative Core. Working in consultation with the other MPI, Dr.
Evan Snitkin, he will provide oversight and scientific direction. As the central infrastructure connecting all aspects
of the proposed work, the Administrative Core will coordinate regulatory and fiscal issues, resource sharing both
internally and externally, and dissemination of findings across all projects and cores. The Administrative Core
will support the proposed program in the following ways:
1. Coordination and management of Center activities
2. Establishing and monitoring overall Center progress
a. External Scientific Advisory Board
b. Annual programmatic meetings and communications with NIAID Program
c. Assisting core research and project leaders with project administration and progress reporting
3. Financial Accountability
4. Resource and data sharing
5. Outreach and dissemination of findings to the larger scientific community
6. Development, implementation, and monitoring of Collaborative Pilot and Emergency Response Projects
7. Training
8. Administration of the Plan for Enhancing Diverse Perspectives